Creating a developmental AIDS Research Center focused on improving the measurement of and response to stigma and structural determinants in the HIV response

Project Summary/Abstract
The overarching goal of these proposed aims is to form the Johns Hopkins-Emory-developmental AIDS
research center (JH-E-dARC) focused on improving the measurement of stigma and interventions focused on
responding to stigma as a threat to both mental health and suboptimal individual and population-level HIV
outcomes in the US and around the world. In response, with the JH-E-dARC we aim to build capacity among
emerging and established investigators globally to study public health responses to stigma. The JH-E-dARC is
proposed as a partnership across the Johns Hopkins School of Public Health and the Rollins School of Public
Health at Emory University, building on more than a decade of partnership in stigma and HIV research funded
by the NIMH, NINR, NIAID, USAID, CDC, amfAR, and MAC AIDS Foundation.
The specific aims for the JH-E-dARC are:
Aim 1. Build local and global capacity to measure and respond to stigma as a risk for both suboptimal mental
health and HIV outcomes (Administrative Core) The Administrative core (AC) will support center research
coordination and output through efficient and effective management structures, sharing of methodological
resources, and support for dissemination. The AC will provide consultative support on grant applications as
well as support IRB applications through review and tracking approvals. In addition, the AC will develop and
maintain the public website for the ARC to communicate the overarching scientific aims and the individual
studies, disseminate results, and provide a hub of resources for stigma measurement and intervention
methodology. Aim 2 Improve the measurement of stigma to better study the impact of attribute-specific and
intersectional stigmas on mental health and HIV (Research Core 1)
The stigma measurement core will support creating rigorous assessment strategies incorporating quantitative,
qualitative, and mixed methods for collecting data to analyze relationships between stigma and mental health
outcomes, including depression, anxiety, and dependency and HIV outcomes in epidemiologic and
interventional studies. Aim 3 Increase the quantity and quality of interventions addressing stigma and
structural determinants of risk in the domestic and global HIV response (Research Core 2)
This intervention core will provide guidance on design of structural and multilevel stigma interventions and
research to study those interventions, including explanatory and pragmatic experimental designs, quasi-
experimental, and observational studies. Aim 4 Support the proliferation of science in measuring and
responding to stigma and structural determinants of HIV among diverse emerging scientists (Developmental
Core) The development core will support capacity development of emerging and established investigators by
providing expert research development support, dedicated mentorship, taking an individualized approach to
capacity building across partners, and by creating knowledge-sharing pathways across the center and beyond.

Public health relevance
Project Narrative In 2023, multiple attribute-specific and intersecting stigmas are critical determinants of poor mental and sexual health of communities at risk for and living with HIV; however, most HIV-related health interventions continue to focus on individual risk behavior. The disconnect between recognizing stigma as a social determinant of health and barrier to HIV interventions and intervention efforts has often been cited as arising from limited capacity of domestic and international investigators to appropriately measure complex stigma processes and develop methodologically sound effectiveness and implementation studies of interventions grounded in theory and lived experience that aim to reduce or mitigate stigma and its harms. In response, we are proposing to develop the Johns Hopkins-Emory-developmental AIDS Research Center (JH-E-dARC) to build capacity for the measurement of stigma and development of interventions focused on responding to stigma as a threat to both mental health and suboptimal individual and population-level HIV outcomes in the US and around the world.